Macrophage senescence as a driver of granuloma failure and progression to necrosis in TB and TB/HIV

ABSTRACT
Understanding the fundamental mechanisms of granuloma breakdown and necrosis in
pulmonary TB lesions is a key unmet need. Lung granulomatous lesions from human
active TB lung lesions show prominent markers of cellular senescence in myeloid
cells, but this aspect of granuloma breakdown has not been well-studied. In the B6.Sst1S mouse model
(where granuloma failure also leads to necrosis) we have identified multiple senescence markers analogous to
those seen in human TB.
Senescent cells are non-replicating, long-lived cells which release signaling molecules (called the
senescence-associated secretory phenotype, SASP) that are locally deleterious and promote tissue
dysfunction. Our central premise is that non-controlling granulomas (both in predisposed humans and in the
B6.Sst1S model) adopt a stress-induced senescence (SIS) phenotype during Mtb infection driven by (i) lipid
peroxidation, (ii) Myc activation, and (iii) unresolving proteotoxic stress. These SIS Ms are (i)
immunosuppressive (MDSC-like), (ii) long-lived and resistant to early death, and (iii) emit deleterious signals
(eg SASP molecules) that inhibit T cell activation and promote recruitment of PMNs and immature Ms. Our
data show that SIS-Ms display a Myc-driven phenotype with oxidative stress, dysregulated proteostasis, and
hyperactivity of the IFN-I pathway. This fuels a self-sustained, escalating cycle that leads to necrosis occurs via
a combination of ferroptotic-like death of SIS Ms and PMN-mediated damage. Underscoring the fact that
senescent cells play a causal role in TB progression, we recently found that a 3-drug cocktail of senolytic
drugs (dasatinib D, quercetin Q, and fisetin F)--designed to kill the deleterious senescent cells--
significantly reduces lung CFU counts and prolongs survival in Mtb-infected B6.Sst1S mice. Thus,
studies of senescence in TB may offer a significant clinical payoff in the form of novel host-directed
therapies (HDT) for TB. [NEW]
In this application we will establish a detailed temporo-spatial understanding of SIS-Ms and surrounding
cells using spatial transcriptomic in 2 species that progress to necrotic TB: B6.Sst1S mice and WT rabbits
(Aim 1). We will exploit the new finding of successful HDT activity by a cocktail of 3 senolytic drugs by optimizing
the 3 drugs and their interactions with Std-Tx (Aim 2). We will also explore the senescence-driven pathologic
pathways in the setting of TB-SIV co-infection using non-human primates (Aim 3).

Public health relevance
NARRATIVE Mycobacterium tuberculosis causes TB in human lungs by triggering aberrant immunological responses that lead to tissue damage eroding lung tissue and enabling the pathogen to spread to other humans by coughing. We have discovered that a key element of this aberrant immune response is that the pathogen triggers immune cells to enter into a senescent state (as is seen in human aging) whereby immune cells lose the ability to respond correctly to the infectious challenge. We propose to use advanced molecular and pharmacologic tools to probe the details of this aberrant senescence response, and then to test novel small-molecule senolytic agents in animal models to see if they have the potential to serve as novel TB drugs.